Imaging Structure and Function of Photoreceptors

Project Summary/Abstract
Human vision starts when photoreceptors collect and respond to light. Normal photoreceptor function is
essential for normal vision, yet techniques to assess these processes in vivo are limited. New optical modalities
that are rapid, specific, and non‐invasive promise to greatly expand our capability to monitor more accurately
and completely photoreceptors.
This study takes advantage of unique adaptive‐optics OCT instrumentation developed in my laboratory in
conjunction with custom algorithms for sub‐cellular image registration and phase‐sensitive detection to
measure anatomical and physiological properties of individual photoreceptors. We will use this technique to
investigate three specific aims that quantify the spectral sensitivity profiles of photoreceptors, the expression of
photoreceptor spectral types in color vision deficiencies, and the temporal dynamics of photoreceptor loss in
retinitis pigmentosa patients. The long term goal of this research is to establish high resolution, high specificity
optical techniques as valid tools for probing structure and physiologic processes of the retina at the cellular
scale. The resulting ability to study cells in vivo will improve early detection of and treatment monitoring for
diseases that impact the retina.

Public health relevance
Project Narrative This study takes advantage of unique camera technology developed in my laboratory for live imaging of cells in the human retina. We will use this camera to investigate how the retina's light‐capturing cells contribute to our vision and how they are affected by retinitis pigmentosa, the most common form of inherited irreversible vision loss. Results of this study may help improve our ability to detect and treat some of the most blinding diseases in the world.